TOPICAL CYSTEAMINE IN THE TREATMENT OF CORNEAL CYSTINE CRYSTAL ACCUMULATION

Cysteamine ophthalmic drops prepared for commercial availability must pose no risk for contamination and subsequent infection. This study is designed to demonstrate conclusively that benzalkonium chloride plus cysteamine is a safe preparation that is effective when administered every waking hour to patients who have nephropathic cystinosis in corneal crystals.